Spatiotemporal dynamics of locus coeruleus circuits during learned behavior

The locus coeruleus (LC), a small brainstem nucleus, is the primary source of the neuromodulator
norepinephrine (NE) in the brain. LC receives input from widespread brain regions and projects throughout the
forebrain, brainstem, cerebellum, and spinal cord. LC neurons release NE tonically to regulate baseline arousal,
and phasically in the context of a variety of sensory-motor and behavioral functions. However, despite its brain-
wide effects, the conditions under which LC-NE neurons are phasically activated and the modes of NE action
during behavior are poorly understood. One prevailing theory suggests that NE acts to control the gain of output
circuits, thereby modulating task performance by enhancing or dampening responses to stimuli. However,
another theory suggests that NE release in cortical output regions acts to reset network activity, enabling task-
switching or learning of new rules. Neither of these theories adequately explains the many observed roles of the
LC-NE system in learning and behavior. We propose a new hypothesis of LC function, that spatiotemporal
dynamics and modular circuits enable dissociated roles for the LC in behavioral execution and reinforcement
during learned behaviors. Here, we propose to examine multiple features of this hypothesis using innovative
approaches combining optically-tagged recordings of specific neuronal populations, advanced 2-photon imaging
of identified neurons and axons, optogenetic manipulation of LC neurons and subpopulations, and computational
approaches to define encoding of task variables by neurons. In Aim 1, we will record and manipulate the activity
of LC neurons in mice performing an instrumentally conditioned task in which they detect auditory tones of
variable intensity, execute a response, and receive positive or negative reinforcement. Using targeted recordings
from LC-NE neurons as well as newly discovered LC-GABA neurons, we will examine the hypothesis that
subsets of LC-NE and LC-GABA neurons encode task execution signals or reinforcement signals. Using this
information, we will use cell-type specific optogenetics to activate or inhibit LC-NE or LC-GABA neurons during
specific task epochs while measuring the effects on behavior. In Aim 2, we will assess anatomical modularity of
LC projections to motor cortex or the prefrontal cortex (PFC), and examine the hypothesis that neurons with
execution or reinforcement responses project preferentially to motor cortex or PFC. Subsequently, we will
modulate the activity of LC neurons projecting to these targets and measure the effects on execution and
learning. In Aim 3, we will examine the hypothesis that differential integration of NE release in motor cortex and
PFC facilitates task execution and learning, respectively. We will monitor the fast kinetics of NE release in motor
cortex and PFC using a genetically encoded NE sensor, and measure the impact on behavior of silencing NE
activity in these cortical targets using optogenetic silencing of LC-NE axons. These data will provide essential
information for a computationally informed theory of the role of LC in cognition, and provide a mechanistic basis
for understanding the role of LC-NE dysfunction in a range of neuropsychiatric disorders.

Public health relevance
The locus coeruleus norepinephrine (NE) system exerts widespread neuromodulatory influence in the brain, but its function in behavior remains elusive, due mostly to a lack of circuit level analysis. Here, we will use cutting-edge approaches to elucidate the causal contribution and computational role of local and output circuits of the locus coeruleus in mice. Such information is critical for understanding the function of NE in cognition, and for providing strong mechanistic basis for its dysfunction in neuropsychiatric disorders.